mDOT Training and Dissemination

Project Lead: Shetty, Vivek Principal Investigator: Kumar, Santosh
mDOT – Technology Training & Dissemination (TT&D)
Abstract:
The mHealth Center for Discovery, Optimization & Translation of Temporally-Precise Interventions (the mDOT
Center) will enable a new paradigm of temporally-precise medicine to maintain health and manage the growing
burden of chronic diseases. The mDOT Center will develop and disseminate the methods, tools, and
infrastructure necessary for researchers to pursue the discovery, optimization and translation of temporally-
precise mHealth interventions. Such interventions, when dynamically personalized to the moment-to-moment
biopsychosocial-environmental context of each individual, will precipitate a much-needed transformation in
healthcare by enabling patients to initiate and sustain the healthy lifestyle choices necessary for directly
managing, treating, and in some cases even preventing the development of medical conditions. Organized
around three Technology Research & Development (TR&D) projects, mDOT represents a unique national
resource that will develop multiple methodological and technological innovations and support their translation
into research and practice by the mHealth community in the form of easily deployable wearables, apps for
wearables and smartphones, and a companion mHealth cloud system, all open-source.
Given that the inherently transdisciplinary, team-based nature of mHealth research requires scientists to cross
disciplinary and institutional boundaries, training and dissemination in mHealth technologies requires a team-
science approach. mDOT will leverage its established and highly successful infrastructure, widely visible
mHealthHUB platform, and deeply-experienced team to develop training and dissemination activities that extend
beyond the collaborative projects (CPs) and service projects (SPs) to involve new research groups with little or
no technological expertise. To achieve its goals, mDOT will pursue the following activities. First, it will provide
direct training activities that leverage annual workshops, conferences, and meetings of professional societies,
and will conduct the annual mHealth training institute to develop a perpetuating cadre of outside researchers
well-equipped to apply mDOT technologies and methods. Second, it will provide “light-touch” outreach using
web-portals with “heavy-touch” outreach activities including training sessions, workshops, and conferences to
inform the scientific community about the technical capabilities and accomplishments of mDOT, and to both
promote and enable a broader use of the mDOT methods and technologies. Importantly, mDOT’s training and
dissemination activities are anchored in an organizing logic model with articulated inputs/outputs. A combination
of Google Analytics and Robotic Process Automation will automate repetitive evaluative tasks to assess the
uptake and impact of the mDOT’s tools via the TT&D activities by a diverse population of mHealth researchers.
1

Public health relevance
Project Lead: Shetty, Vivek Principal Investigator: Kumar, Santosh mDOT – Technology Training & Dissemination (TT&D) Public Health Relevance: mDOT will grow a new generation of transdisciplinary mHealth researchers who are well-equipped to apply mDOT technologies and methods to discover, optimize, and deploy temporally-precise mHealth interventions. Adoption of mDOT technologies will give rise to a new research paradigm and transformatively improve health and disease outcomes by enabling patients to initiate and sustain the healthy lifestyle choices necessary to prevent and/or successfully manage the growing burden of multiple chronic conditions. 2